A novel microfluidic platform to study exosome biology in PAH.

The endothelium is the cellular monolayer that covers the inner lining of the entire circulatory system. Endothelial
dysfunction is a feature of pulmonary arterial hypertension (PAH), a life-threatening disease associated with
abnormally high pulmonary pressures and chronic right heart failure. Due to the limitations of available static cell
culture and animal models, our understanding of the mechanisms that orchestrate the initiation and perseverance
of endothelial dysfunction in PAH remains incomplete. Given that endothelial dysfunction is a common finding in
PAH, an understanding of the mechanism behind maladaptive endothelial responses could help accelerate the
discovery of novel therapies for PAH. Presently, it is believed that endothelial derived exosomes contribute to
PAH by carrying signals that trigger maladaptive endothelial responses in the setting of injury. Exosomes are
cell-derived small (~30-150 nm) extracellular vesicles that carry proteins, metabolites and nucleic acids involved
in a variety of physiological and pathological processes. While it is known that exosomes carry molecular and
genetic factors associated with angiogenesis, inflammation and vasoreactivity, a comprehensive assessment of
exosome cargo of healthy and dysfunctional PMVECs has been hindered by current low-yield exosome isolation
techniques. These techniques cannot perform real-time dynamic exosome isolation from pulmonary
microvascular endothelial cells (PMVECs) exposed to PAH-associated stressors. To address this unmet need,
we have designed the MFES (Multifunctional Exosome Sorter) that can dissect the whole exosome population
into subpopulations based on size and surface markers. MFES is the first lab-on-a-chip platform that integrates:
1) a vessel-on-a-chip module for real-time characterization of PMVEC functional responses across a wide range
of physiological and pathological parameters, 2) a module for high-yield exosome size-based isolation, 3) a
surface marker based exosome sorting using magnetic beads, and 4) multi-omics phenotyping of exosomes of
PMVECs. Here, we are proposing a technology that can enable broadly to investigate the two main defining
characteristics of exosomal subtypes, i.e., size and surface markers, both separately independently, and in
combination sequentially. We will characterize changes in exosome cargo in healthy and PAH PMVECs exposed
to shear stress-related conditions in the MFES. We will isolate subpopulations of exosomes based on size and
surface markers and characterize them for their cargo (Aim 1). Then, we will determine whether exosomes
derived from stressed PMVECs can induce pathological changes in healthy PMVECs cultured in a microfluidic
culture chip (Aim 2). This technological innovation enables to study endothelial exosome biology in a setting that
represents the flow dynamics associated with PAH. Further, the use of cutting-edge -omics technologies,
bioinformatic analysis integrated with machine learning algorithms to analyze the purified exosomes is expected
to yield a comprehensive dataset of exosome cargo profiles and open exciting opportunities for investigating the
biological role of exosomes in PAH pathobiology and the testing of novel therapeutic agents.

Public health relevance
Due to the limitations of available static cell culture and animal models, our understanding of the mechanisms that orchestrate the initiation and perseverance of endothelial dysfunction in pulmonary arterial hypertension (PAH) remains incomplete. The endothelial cell derived exosomes, small (~30-150 nm) extracellular vesicles, contribute to PAH by carrying signals that trigger maladaptive endothelial responses in the setting of injury via molecular and genetic factors associated with angiogenesis, inflammation and vasoreactivity. However, a comprehensive assessment of exosomal cargo of healthy and dysfunctional pulmonary microvascular endothelial cells (PMVECs) has been hindered by current low-yield exosome isolation techniques that integrates real-time exosome capture from PMVECs exposed to PAH-associated high shear stress. We propose to develop a lab-on-a-chip platform technology, Multifunctional Exosome Sorter (MFES), that can dissect the whole exosome population into subpopulations based on size and surface markers integrating; (i) a vessel-on-a-chip module, (ii) a high-yield exosome size-based isolation module, (iii) a magnetic bead-based surface biomarker sorting chamber, and (iv) multi-omics phenotyping of exosomes investigating the biological role of exosomes in PAH pathobiology, where such a technological innovation will uniquely enable to study the biology of exosome subsets associated with flow dynamics in PAH.